Organizing 14th International P53 Meeting

[unreadable] DESCRIPTION: Not provided by the applicant [unreadable] [unreadable] Public Health Relevance: Not provided by the applicant [unreadable] [unreadable] [unreadable]

Public health relevance
Not Applicable (not irrelevance to R13)